Further assessment of durability of a gene editing therapy for Duchenne muscular dystrophy

Project Summary
Gene editing offers an innovative approach for gene correction that can permanently edit the
patient’s own DNA. To inform how permanent editing may translate to long-term clinical benefit,
durability must be characterized in preclinical animal models. Here a gene editing therapy for
Duchenne muscular dystrophy that targets deletion of DMD exons 45-55 to restore the reading
frame for 50% of all patients will be assessed in a humanized mouse model. This approach is
advantageous because it maintains the normal gene regulation and retains three times more of
the protein coding sequence than mini/micro-dystrophin gene replacement approaches for
Duchenne. This therapy uses systemic adeno-associated virus delivery of CRISPR/Cas9 to edit
DNA in muscles throughout the body. In this study, functional efficacy (through non-invasive
muscle function measures), restoration of molecular markers (including dystrophin, the
dystrophin-glycoprotein complex, histopathology and blood biomarkers) and pilot toxicity readouts
will be compared at 2 months versus 6 months post-dosing. Two different immune suppression
regimens and three different dosing levels will be tested in juvenile hDMD del45 mdx mice. This
work will clarify the long-term durability of gene editing efficacy and how it is influenced by dosing
regimens. Learnings from this proposal will have wide applicability to other gene editing therapies
which target post-mitotic tissues. As recommended in FDA Guidance, these data will be included
in future IND filings and will help advance development of an innovative gene editing therapy for
Duchenne muscular dystrophy to clinical studies and then commercialization.

Public health relevance
Project Narrative In vivo gene editing therapies are designed to permanently correct mutations in a patient’s own DNA and therefore may show more robust durability than non-integrating approaches. In this project, the durability of an AAV-delivered gene editing therapy for Duchenne muscular dystrophy will be compared at 2 and 6 months in a humanized mouse model. This work will address FDA recommendations for preclinical assessment of durability for a therapy designed to restore the reading frame for 50% of Duchenne muscular dystrophy patients.